Clinical Protocol and Data Management

PROJECT SUMMARY/ABSTRACT
CLINICAL PROTOCOL AND DATA MANAGEMENT
The Clinical Protocol and Data Management (CPDM) oversees all cancer clinical research at Winship Cancer
Institute of Emory University (Winship). CPDM has three objectives: (1) supporting safe and ethical conduct of
innovative and transformative clinical research; (2) promoting high-quality data generation; and (3) increasing
trial access for patients in the catchment area, emphasizing underrepresented populations. CPDM includes the
Winship Clinical Trials Office (CTO), clinical data management team, regulatory specialists, quality management
(QM), training/education, and the Data Safety and Monitoring Committee (DSMC). This research infrastructure
is led by interim Associate Director for Clinical Research Edmund Waller, MD, PhD (CI), and CTO Medical
Director R. Donald Harvey, PharmD (DDT), under the direct leadership of Winship Executive Director Suresh
Ramalingam, MD (DDT). CTO operational leadership is provided by CTO Director Amy Overby, who oversees
all clinical research staff and a group of experienced managers across each CTO function. The CTO provides
infrastructure including trial development, activation, conduct, data collection and analysis, and QM monitoring
(including in-person/remote site) and audits with a specialized team focused on multi-institutional trials. In
addition, the CTO provides orientation and ongoing training for Winship members, faculty, and staff across all
aspects of clinical research. The clinical data management team and regulatory specialists are organized by
cancer site and treatment modality working groups. The Winship trials portfolio is balanced between institutional,
industry-sponsored, externally peer-reviewed, and NCI-supported National Clinical Trials Network (NCTN) and
Experimental Therapeutics Clinical Trials Network (ETCTN) trials. The DSMC oversees implementation of the
Winship Data Safety and Monitoring Plan (DSMP) to ensure a high level of compliance. During the 2017-2021
funding period, 936 interventional and non-interventional protocols were activated at Winship. CPDM also
supported the recruitment of 3,940 accruals to interventional treatment trials (representing a 23% increase
compared to prior reporting period) across 732 protocols; approximately 41% of enrollments were on institutional
or externally peer-reviewed trials. Of these, Black patients comprise 25% of the interventional treatment accruals
at Winship, which is comparable to the proportion of Black cancer patients in Georgia. The DSMC monitored
358 protocols, resulting in 549 reviews of IITs and national group trials. Analyses of performance metrics for trial
conduct demonstrate steady improvements in key measures including accrual, activation times, and protocol
compliance. Currently 333 adult therapeutic clinical trials, and 97 pediatric therapeutic trials are open to
enrollment at Winship. During the next funding period, Winship will continue to increase patient accrual with an
emphasis on the affiliate sites and continued focus on historically underrepresented groups.